Structure and regulation of the vacuolar ATPase

Project Summary The proton-pumping vacuolar ATPase (V-ATPase; V1Vo-ATPase) is an essential enzyme complex found in the endomembrane system of all eukaryotic organisms and in the plasma membrane of some animal cells. The V-ATPase functions in ATP hydrolysis-driven acidification of subcellular compartments or the extracellular space, a process vital for basic cellular processes including endocytosis, protein trafficking, bone remodeling, urine acidification, sperm maturation, and neurotransmitter release. Loss of V-ATPase in animal cells is embryonic lethal, while partial loss of function (or hyperactivity) has been linked to numerous human diseases, such as renal tubular acidosis, osteoporosis, diabetes, male infertility, neurodegeneration, cancer, and AIDS. Fighting these diseases on a molecular level will require a detailed understanding of the structure, catalytic mechanism, and regulation of the eukaryotic V-ATPase complex. In cells, V-ATPase activity is regulated by a unique mechanism referred to as reversible disassembly, a condition under which the complex dissociates into V1-ATPase and Vo proton channel sectors that are both functionally silenced. Despite its important role in V-ATPase function, the molecular mechanism of activity regulation by reversible disassembly is poorly understood, a gap in knowledge that is largely due to the lack of high-resolution structural information and a defined in vitro model system to study the process under controlled conditions. The immediate goal of this project is to obtain high-resolution structural and mechanistic information aimed at a better understanding of V-ATPase regulation and to uncover non-canonical functions of the V- ATPase Vo membrane sector that may play a role in neuronal communication. We will address these questions with the following specific aims: (1) Molecular determinants of V-ATPase assembly and disassembly (2) Non-canonical functions of the V-ATPase Vo membrane sector. We study the structure and regulation of the yeast V-ATPase, a powerful model system for the mammalian enzyme due to the high level of conservation of the enzyme's structure and mechanism across species, the ease of genetic manipulation, and the ability to obtain highly purified enzyme with a defined subunit composition. The long-term objective of the project is to develop strategies aimed at either promoting or inhibiting the process of reversible disassembly of the human V-ATPase that will allow modulation of the activity of the enzyme in a tissue and subunit isoform dependent manner for therapeutic purposes.

Public health relevance
Project Narrative The proton-pumping vacuolar ATPase (V-ATPase; V1Vo-ATPase) is a large, multisubunit enzyme complex that is essential for numerous fundamental cellular processes in all eukaryotic organisms. A defective or hyperactive V-ATPase can be associated with devastating human diseases such as renal tubular acidosis, osteoporosis, diabetes, neurodegeneration, cancer, and AIDS. Understanding the molecular origin of these diseases requires a detailed knowledge of the structure and regulation of the disease causing bio macromolecules. This proposal requests funds for determining high-resolution structures of the enzyme's catalytic (V1) and proton channel (Vo) sectors, elucidating the V-ATPase's unique mode of regulation, and for exploring non-canonical ion-conducting functions of the V-ATPase membrane sector. The long-term goal of the project is to gain a molecular understanding of V-ATPase's role in human disease and to identify ways to modulate the activity of the disease causing enzyme.